Interplay between reverse transcription and host restriction

Infectious agents have infected prokaryotes and eukaryotes throughout evolution. Indeed, there is co-evolution
of organisms and their infectious agents, with development of protective responses in the hosts and adaptive
countermeasures by the infectious agents. Infectious endemic retroviruses like murine leukemia virus (MLV)
have existed in mice for millions of years and provide us with an outstanding model system to understand how
mammalian hosts suppress virus replication and conversely, how viruses counteract this restriction. One system
of viral restriction is conferred by the apolipoprotein B mRNA editing enzyme, catalytic peptide 3 (A3) family of
proteins, which are packaged into retroviruses in virion-producing cells and after infection of target cells, either
block reverse transcription or deaminate deoxycytidine residues in single-stranded DNA, resulting in uracils and
G-to-A mutations in the viral genome. The products of retrovirus reverse transcription (ssRNA, ssDNA and
dsDNA) are also sensed by host nucleic acid sensors. Sensor binding to viral nucleic acid leads to the production
of anti-viral cytokines and chemokines, such as type I interferons, which “warns” surrounding cells to arm
themselves against infection by producing proteins such as A3. These host anti-viral events are believed to occur
largely in the cytoplasm, where A3 proteins and many host sensors are believed to function.
Retroviruses enter cells when the viral and host membranes fuse and capsids are deposited in the
cytoplasm. Reverse transcription initiates from within the capsid and capsid dissociation and reverse
transcription are mutually dependent; because DNA is more rigid than RNA, without capsid dissociation, reverse
transcription cannot proceed and conversely, the generation of DNA facilitates capsid dissociation. The reverse
transcription complex not only consists of viral RNA, DNA and the viral proteins reverse transcriptase and
integrase, but viral capsid and other proteins such as the MLV protein p12, which is needed for tethering of the
proviral DNA to host chromatin to achieve integration.
Recently, there has been much debate as to whether reverse transcription occurs solely in the cytoplasm or
in the nucleus or both. Our lab pioneered the use of in vivo mouse models to study how A3 proteins restrict
retrovirus infection and has used A3 and nucleic acid sensor knockout (KO) mice and genetically engineered
animals that express human A3 proteins in these studies. Our data, based on our analysis of A3 KO mice and
cells, suggest that the initial step occurs in the cytoplasm but that reverse transcription may also occur in the
cytoplasm. With these mouse models, we have the tools to carry out in vitro, ex vivo and in vivo studies to
determine how A3-mediated restriction and sensing of reverse transcripts are integrated with reverse
transcription and nuclear entry for MLV and its natural host, the mouse. To accomplish this, we propose 3 aims,
that will determine: I. Where in the cells APOBEC3 proteins block reverse transcription or deaminate viral
DNA; II. What stage in reverse transcription and where in the cell the host base excision repair enzyme,
UNG, removes uracil from APOBEC3G-deaminated viral DNA and the consequences of this for viral
escape; III. Whether host sensing of viral nucleic acid takes place in the cytoplasm, nucleus or both
compartments. Determination of when and where these events occur is critical to understanding how
retroviruses, including HIV, evade host immunity and the identification of which steps are likely to be the best
targets for interventional therapies at the early stages of infection.

Public health relevance
Retroviruses are major causes of disease in animals and humans that replicate by reverse transcribing viral RNA into DNA. The initial immune response to retroviral infection is critical to the ability to clear infection, because once the viral DNA integrates into the host chromosomes, persistent infections arise, leading to diseases such as cancer and immunodeficiencies. Here we will examine the timing and location of virus replication and host response, using unique cell culture and mouse models developed by our lab.